26 WK STUDY TO EVALUATE SET WHEN BRL 49653C ADMINISTERED TO PATIENTS WITH NIDDM

The purpose of this study is to find out whether the drug BRL 49653C when combined with insulin is effective in treating patients who have non-insulin dependent diabetes mellitus. Safety and tolerability will also be evaluated.